Single-cell and single-molecule profiling of protein-DNA interactions by MACHA

Summary
Protein-DNA interactions are fundamental to DNA-dependent processes such as transcription, replication,
DNA repair, and chromosome organization in all domains of cellular life. Enrichment-based methods to detect
protein-DNA interactions are widely used to obtain genome-wide high-resolution maps of transcription factor
binding and chromatin states. However, these methods have severe shortcomings when applied to single cells.
In single-cell applications, enrichment-based methods cannot distinguish between unbound DNA and
unsuccessful recovery of protein-bound DNA since both lead to absent DNA fragments and the sparse data
makes it difficult or impossible to obtain cell-type-resolved binding profiles of transcription factors starting from
complex tissues. This limitation significantly reduces the information content of single-cell data. MACHA will
detect protein-DNA interactions in cells as cytosine methylation catalyzed by an exogenous GpC
methyltransferase (GpCMTase) that is directed to protein-bound DNA by a primary antibody recognizing the
protein of interest.

Public health relevance
Project Narrative While protein-DNA interactions are fundamental to highly cell-type-specific DNA-dependent processes such as transcription, replication, DNA repair, and chromosome organization, their detection using single cell and single molecule approaches remains difficult or even impossible.We will develop a novel enrichment-free chromatin protein profiling method, MACHA, to measure protein-DNA interactions in singlecellsand on single molecules in human cell lines and tissues.